The Role of Androgens in Amygdala Subnuclei Development Across Human Adolescence

Abstract The human amy ygdala is a c in structure made up of a number of nuclei, which together are vital for complex brai an array of emo 18-23 otional and s viors that con evelop across adolescence. While a number social behav ntinue to de of structural MR ave examined sex differe mygdala maturation, these studies have reported RI studies ha ences in am mixed findings.12-17 Moreove tudies sugge cific and heterogeneous effects of testosterone er, animal st est sex-spec on the developm of var subnuclei within the amygdala.8-10 However, confirming similar patterns o ment rious r of growth in humans has been n limited by the inability ly segment amygdala subnuclei in adolescents y to precisel using MRI. Using a large NIH-funded im etic, and hormone adolescent dataset (N=450; ages 10-18 maging, gen yrs.; PI: Nagel), the current proposal aim ms to adapt a new in vivo amygdala segmentation approach to assess structural segme entation of amygdala s cross adolescence. Following individually based subnuclei subnuclei ac delineation, we a determine ho rone levels and androgen receptor (AR) sensitivity relates to also aim to d ow testoster neurotypic amy subn volum in adolescent oys and girls. Elucidating struc sexua ygdala nuclei mes bo g tural al dimorphisms in amygdala s humans ma ur understanding of amygdala development, as subnuclei in ay aid in ou well as ultimately help us to understan sex differences in various behaviors and risk for disease.7 nd life-long s Moreover, this r research wil ly contribute ger field of developmental neuroscience, as the ll significantl e to the larg current study ai date a meth process by which we can segment amygdala subnuclei in ims to elucid hodological p developing samp methods sh eful to a wide array of researchers who may wish to create ples. These hould be use specific normativ inical pediatr s for future structural, functional, and diffusion MRI studies. ve and/or cli ric templates

Public health relevance
Project Narrativ ve Discrepancies e structural M exist in the MRI literature as to how age-, sex-, and puberty influence amygdala development.12-1 The use o ed, age- an ecific in vivo MRI segmentation techniques, as 17 of fine-grain nd region-sp well as the con of possible eity in the nsideration e heterogen development of distinct subnucle within the ei e amygdala, are re understandi equired to advance our ing of human amygdala development in boys and girls. The current project aims to 1) establish th he methods needed to adapt a novel in vivo approach to quantify snhy amygdala subnu ntation in ad as well as 2) examine how sex, testosterone, and androgen uclei segmen dolescents, a receptor (AR) se fluence subn opment in a large typically developing adoles ensitivity inf nuclei devel scent sample (N=450, ages 10 the necess 0-18 yrs.). E ary methodology to segment pediatric amygdala subnuclei Establishing and examining h subnuclei de crucial next steps towards expanding our knowledge about how these s evelop are c the human amyg gdala.